The Gut-Lung Axis: Immunometabolism Linking the Gut Microbiome and Lung Imunity

Project Summary/Abstract
The gut-lung axis is one of many communication axes between the gut microbiome and extra-intestinal
systems, organs, and tissues. This axis has been shown to strongly influence lung immune and inflammatory
responses, primarily in allergic asthma inflammation and lung infections. The mechanisms for this
communication are speculated to be immune cell reprogramming and/or direct translocation of factors,
including microbial ligands. This project focuses on the latter mechanism, namely the direct effects of gut
microbiome products that make their way into circulation, on lung tissue. The goals of this proposal are to
rigorously investigate 1) the gut-lung axis with a focus on metabolites, such as short-chain fatty acids (SCFAs),
and commensal-associated molecular patterns (CAMPs), 2) the lung cells that integrate these gut-derived
signals, and 3) the effects of these signals of the responsiveness of the lungs to sterile and infectious injury.
Based on our preliminary data, we propose that SCFAs and CAMPs are released by the gut microbiota and
travel to the lung where they affect the immunometabolic programming of resident immune and non-immune
cells, such as alveolar macrophages (AM) and alveolar type 2 (AT2) cells. In Aim One, we will perform
metabolomics analysis of stool and lung tissue as well as intervening tissue and vascular beds. This aim will
also assess the role of SCFA-producing microbiota in establishing the lung’s baseline metabolite profile and
track the migration of specific CAMPs from the gut to the lung. In Aim Two, we will focus on identifying the lung
cells that are capable of sensing both CAMPs and metabolites and how they contribute to the lung adopting a
primed “ready” state or an unprimed “unready” state vis-à-vis infection and injury. Furthermore, the effect of
these CAMPs and metabolites on the metabolic program of the lung in general and the specific lung cells will
be examined. In Aim Three, we will explore ways to manipulate the gut-lung axis through antibiotic use, diet,
focused metabolite delivery, and through microbiome transfer or restoration. These studies will attempt to
establish conditions whereby microbiome-based therapies may help restore healthy lung immune
responsiveness. In summary, this project seeks to understand the role of the gut microbiome and dietary
metabolites in maintaining healthy lung immunity. Overall, we anticipate that these studies will help
fundamentally increase our knowledge of the direct acting effects of the gut microbiome on lung immune
responses and in doing so provide valuable insights towards designing future novel therapeutic options that
take advantage of the gut-lung immune axis.

Public health relevance
Project Narrative This study focuses on uncovering new biology underlying the gut-lung immune axis, which has been shown to regulate specific inflammatory processes in the lung. We will systematically study gut microbiome-derived factors that directly influence lung immunity, lung cells that integrate these signals, as well as explore the molecular basis for manipulating or disrupting the gut-lung axis in health and disease.